Radiotheranostic host:guest pretargeting with Pb-203 and Pb-212

Project Summary
For monoclonal antibody(mAb)-based radiopharmaceuticals to widely impact precision nuclear medicine,
strategies that both improve the convenience and reduce the radiation burden to non-target organs are urgently
needed. Compared to direct-labeling strategies, pretargeting makes mAb-based nuclear imaging and targeted
radionuclide therapy (TRT) safer, but it has yet to realize its potential impact on clinical precision nuclear
medicine. However, the modest successes and inherent limitations of existing pretargeting platforms have
defined that a successful platform needs: 1) to be nonimmunogenic, 2) designed to be modular and tunable to
any mAb and radionuclide, and 3) to avoid clearing agents. To date, no platform has met these criteria, and there
remains a critical need for pretargeting strategies to improve precision nuclear medicine.
The long-term goal of this proposal is to develop a host:guest pretargeting platform that utilizes curcubit[7]uril
(CB7) “hosts” and adamantane (Adma) radioligand “guests” for nuclear imaging and TRT with elementally-
matched 203Pb (imaging) and 212Pb (therapy). CB7-Adma host:guest pretargeting is based on nonimmunogenic
molecules, uses a modular approach, and can achieve high uptake in target tissues using mAb targeting vectors
with lag times that nullify the need for clearing agents. Thus, it is hypothesized that this platform will address the
shortcomings of other platforms yielding a translatable radiotheranostic approach to cancer treatment.
Specific Aim 1 of this proposal is the “Development and evaluation of 203/212Pb-labeled radioligands for
pretargeting.” To achieve this goal, a library of radioligands will be synthesized and evaluated in vitro as well as
in vivo, optimizing the parameters of the host:guest pretargeting approach and comparing the dosimetry to a
direct-labeling strategy in order to demonstrate the platform’s suitability for clinical translation
Specific Aim 2 is the “Evaluation of 212Pb pretargeted alpha-TRT in murine xenograft models.” Using the
strategies for pretargeting developed in Specific Aim 1 as well as a fractionated dosing approach, we will
establish the efficacy of our host:guest pretargeting for alpha-TRT. We will also compare the dosimetry,
therapeutic index, therapeutic efficacy, and radiological toxicity to analogous approaches with directly-labeled
mAbs in a mouse model of cancer to validate the advantages.
Successfully achieving the aims of the proposed studies will lead to the development and validation of a next
generation pretargeting platform that is suitable for future translational studies and demonstrate its potential as
an innovative theranostic application for TRT. The platform will be a robust, safe, and convenient alternative to
direct-labeling strategies for mAbs that is widely applicable to precision nuclear medicine in human disease.

Public health relevance
Project Narrative The proposed project is relevant to public health because it will develop a pretargeting platform for precision nuclear medicine that will reduces the harmful radiation-related toxicity of antibody-based radiopharmaceuticals. The platform will be a robust, safe, and convenient alternative to standard approaches with antibody-based radiopharmaceuticals that is widely applicable to enhancing human health through precision medicine, which is directly applicable to the mission of the NIH.